Precision Lead Delivery for Advanced Conduction System Pacing

Summary
The cardiac conduction system (CCS) is a new target for pacing that is rapidly replacing traditional heart
stimulation due to its overwhelming advantages. Precise CCS lead delivery is limited by the absence of specialized tools.
We propose a novel lead delivery platform to precisely identify and safely deliver CCS pacing leads. We will develop a
3D pre-shaped delivery catheter with a novel feature to enable physicians to monitor pacing parameters, implant depth
and CCS capture with minimal damage to heart tissues.
Traditional right ventricular (RV) apical pacing is a well-established technology with more than 1MM implants
annually but with a possibility of left ventricular dysfunction and heart failure. CCS pacing (CSP) is devoid of these
complications. The latest technique for CSP, Left Bundle Branch (LBB) Area Pacing (LBBAP), is improved over the earlier
direct His bundle pacing (easier target and stable pacing parameters). The pacing lead is delivered through a pre-shaped
catheter and advanced deep into the interventricular septum in the vicinity of LBB. LBBAP is still limited by poor
localization of the exact target, potential need for multiple probing attempts with the entire lead, and absence of
specialized tools to minimize the effort and damage to the septum.
The core novelty of our approach is in the idea of using a delivery system that will allow the physician to sequentially
map the septal myocardium, fix the delivery catheter at the optimal location, followed by lead delivery at the optimal
site.
We have fabricated initial functional prototypes and used these in representative models. Initial bench and ex-vivo
testing supports improved lead delivery mechanics and precision. Reduced tissue trauma with the novel delivery system
was also initially appreciated. This preliminary work and prior experience position us well to further develop this novel
concept. As part of this Phase I program we will accomplish the following specific aims:
Specific Aim 1 - Develop fully functional catheters and stylet prototypes.
• Task 1.1 Design 3-5 iterations of the 3D pre-shaped lead delivery catheter with a second braid-embedded stylet
lumen and extendable electrically insulated pacing and mapping stylet with radio-opaque markers.
• Task 1.2 Perform mechanical and electrical characterization of the catheter and stylet (torque, stiffness,
interoperability, impedance, etc.).
Specific Aim 2 - Demonstrate stability and precision of delivery system in a bench model with experienced clinicians.
• Task 2.1 Fabricate representative right heart models based on CT data.
• Task 2.2 Perform simulated lead delivery using stylet-based and conventional methods. Compare procedural
characteristics between the standard and prototype delivery systems and stylets based on the 9-partition
septum model. Deliverability appropriate segments and quantitative operator feedback to be assessed and
compared between systems.
Specific Aim 3 - Assess overall system performance and tissue damage to the septum from stylet vs. lead helix.
• Task 3.1 Perform simulated lead delivery in an ex vivo electrically active sheep heart model compared to
conventional delivery systems/leads including procedural characteristics, pacing parameters and assessment of
tissue damage with both methods.
• Task 3.2 Evaluate different stylet prototypes and compare recording/pacing characteristics with standard leads.
• Task 3.3 Develop initial US regulatory strategy including potential FDA pre-submission meeting.
The goal of this project is to address key shortcomings in LBBAP using a novel delivery catheter. This will enable
more precise, faster and safer lead delivery in a rapidly expanding population of patients.

Public health relevance
Project Narrative Conduction system pacing is the most recent advance in cardiac stimulation. Compared to traditional right ventricular apical pacing it improves the well-being and survival of a significant patient population. This proposal is to develop an innovative catheter delivery system that allows for a step-by-step mapping and navigation in the target area of interventricular septum, atraumatic determination of pacing site suitability and a precise delivery of the permanent pacing lead to the effective destination.